Perinatal depressive symptoms and infant self-regulation: Pathways through infant autonomic regulation and postnatal maternal sensitivity

PROJECT ABSTRACT/SUMMARY
Offspring of mothers with depression are at threefold risk of developing depression themselves, known as
the intergenerational transmission of depression (IGTD). Self-regulation (SR) impairments are conceptualized
as a vulnerability linking maternal and offspring depression. In infancy, SR develops in the context of infant-
caregiver interactions requiring both infant and caregiver contributions. However, elevated maternal perinatal
depressive symptoms—which affect one in five mothers—may hinder infant SR development. Specifically,
prenatal symptoms may undermine infant physiological regulation while postnatal symptoms may undermine
sensitive parenting, both of which are critical for infant-caregiver interactions that support SR. Thus, infants
exposed to different timing patterns of perinatal depressive symptoms (prenatal, postnatal, or both) may
experience different mechanisms of risk (i.e., prenatal symptoms may affect SR through impaired infant
physiological regulation while postnatal symptoms may affect SR through reduced sensitive parenting).
Importantly, these pathways likely interact to produce particularly heightened risk in the case of perinatal
symptoms occurring across both the pre- and postnatal periods. The present study uses a leading-edge
analytical approach to examine 1) the specific timing effects of prenatal only, postnatal only, or both pre- and
postnatal depressive symptoms on infant SR and 2) the two potentially interacting pathways linking maternal
perinatal symptoms to infant SR. In a longitudinal sample of 168 pregnant women, prenatal maternal
depressive symptoms are assessed at 34-35 weeks gestation; postnatal maternal depressive symptoms, infant
autonomic regulation, and maternal sensitivity at 2 months postpartum; and infant SR at 6 months postpartum
to address my specific aims. With the support of the NRSA fellowship and my mentoring team, I will complete
the proposed research and my training goals, which are to 1) integrate my existing knowledge of the perinatal
and infancy periods and infant SR into models of the IGTD; 2) develop expertise in processing and
interpretation of cardiorespiratory indices of autonomic functioning; 3) gain experience in behavioral coding of
infant SR; 4) advance my expertise in quasi-experimental approaches for strengthening causal inference by
integrating concerns about developmental timing and causal mediation; and 5) engage in professional
development and ethics training. By identifying which dyads are most at risk for SR difficulties and how that
risk is transmitted, the proposed project will inform targeted prevention and intervention efforts that reduce
difficulties in SR during infancy and thus interrupt the IGTD, addressing a clear public health need. The training
I will receive with the support of this NRSA fellowship will also prepare me to achieve my career goal of
becoming a professor at an R1 research institution and continuing to pursue a research program aimed at
understanding and interrupting the IGTD and reducing the substantial burden of depressive symptoms on
individuals and our broader society.

Public health relevance
PROJECT NARRATIVE Maternal depressive symptoms during the perinatal period are highly prevalent and have long-term implications for offspring mental health, including a three-fold risk of developing depression in adolescence and adulthood, but understanding of the specific pathways through which perinatal depressive symptoms affects offspring development is currently limited. The present proposal will address this limitation by examining two proposed pathways linking maternal with offspring depression, with a particular focus on a) specific timing effects of prenatal only, postnatal only, and more chronic (pre- and postnatal) depressive symptoms; b) infant autonomic regulation and maternal parenting behaviors as potentially interacting mediators of risk; and c) implications for self-regulation in infancy, which is a key vulnerability identifiable in infancy that contributes to risk for depression in adolescence and adulthood. By identifying which dyads are most at risk for self- regulation difficulties (based on timing of depressive symptoms) and how that risk is transmitted, the proposed project will inform targeted prevention and intervention efforts that reduce difficulties in self-regulation during infancy and thus interrupt the intergenerational transmission of depression, addressing a clear public health need.